IND-enabling development of a long-duration antagonist to treat opioid overdose

PROJECT SUMMARY / ABSTRACT
More than 80,000 Americans died in 2021 from fentanyl and other high-potency opioids. The emergence of
illicit, highly potent synthetic opioids such as fentanyl is a key contributing factor to the recent spike in opioid-
related mortality, increasing ten-fold since 2016. While the mu opioid receptor (MOR) antagonist naloxone has
proven invaluable as an opioid overdose antidote, naloxone suffers from a very short duration of action (half-
life ~1 hour) and is less effective against newer, longer-acting opioids, including fentanyl (half-life ~7-10 hours).
This leads to a highly lethal and increasingly prevalent phenomenon known as “renarcotization,” whereby an
overdose patient revived with naloxone re-enters an overdose state from residual fentanyl in the body.
To counter renarcotization, naloxone must be given repeatedly and at significantly higher doses. While usually
achievable in a hospital, renarcotization is often not recognized or monitored for outside of a medical setting
and may lead to unexpected death. A critical, unmet need exists to develop a long-acting MOR antagonist
formulation that prevents renarcotization by providing 12-24 hours of protection to allow opioid levels to drop
below dangerous levels.
The objective of this project is to advance development of CP216, a novel, long-acting naloxone formulation that
utilizes an innovative design to address both primary and secondary overdose through a combination of free
form naloxone for immediate effect and microencapsulated naloxone for sustained protection. This new
formulation will be especially useful in rural areas, where access to emergency medical services is often delayed,
or for Warfighters poisoned by weaponized opioids that need sustained protection while transported to
definitive medical care.
Other attempts to address renarcotization using high or frequent doses of naloxone or nalmefene have limited
protection for high-potency opioids and can induce precipitated opioid withdrawal (POW) in those with opioid
dependence. POW is a severe and potentially life-threatening condition and for this reason causes some
overdose victims to refuse continued naloxone treatment after rescue. Still other efforts to chemically modify
naloxone are subject to significant regulatory and technical risk. Consegna’s drug (CP216) is approvable through
the accelerated 505(b)(2) regulatory pathway and is, according to recent studies, unlikely to induce POW and
would therefore gain more acceptance among overdose patients.
Consegna believes this project will have a positive impact on public health by leading to the first safe and
effective product to completely address renarcotization.

Public health relevance
PROJECT NARRATIVE While naloxone is an effective opioid overdose antidote, in many cases its short half-life is ineffective against synthetic opioids with longer half-lives, such as fentanyl, leading to a phenomenon called renarcotization (whereby an overdose patient revived with naloxone re-enters an overdose state from residual opioid in the body after the naloxone wears off). The objective of this project is to create a better pharmacokinetic profile for naloxone delivery that continuously maintains naloxone at therapeutic levels long enough to prevent renarcotization. This novel product will directly lead to saving lives of opioid overdose victims.